Administrative Core

The Collaborative Study on the Genetics of Alcoholism (COGA) is a tightly integrated and interdisciplinary
project, whose overarching goals are to understand the contributions and interactions of genetic, neurobiological,
and environmental factors on risk and resilience over the developmental course of AUD, including relapse and
recovery. COGA is a family-based study of large, ethnically diverse families, some densely affected by AUD,
and family members have been characterized in clinical, behavioral, neuropsychological, neurophysiological, and
socio-environmental domains, yielding a rich phenotypic dataset paired with a large repository of biospecimens
and genomewide SNP data (GWAS) in 12,145 family members. The breadth and depth of longitudinal
assessments in COGA families allow genomic analyses to be conducted within a developmental context,
allowing inferences regarding genetic susceptibility and environmental malleability, which may contribute to
avenues for prevention and intervention.
COGA builds on the key strengths of our research achievements over the past 30 years toward our central
mission, to understand the genetics of AUD and its interplay with environment. In response to RFA-AA-19-001,
we propose three inter-related and inter-dependent projects (Genomics, Brain Function, Lifespan) supported by
3 essential cores (NIAAA-COGA Sharing Repository (NCSR), Data Management, and Administrative). The
projects and cores harness the diverse expertise of the COGA team and the close collaboration among COGA
investigators resulting in tight integration and progress toward COGA's goals. Consistent with the RFA and in
keeping with COGA's research agenda, the overarching specific aims for the next five years are:
Aim 1: Characterize loci, genes, polygenic risk and biological pathways underlying alcohol use and AUDs, and
identify the genomic and cellular/neuronal signatures that contribute to alcohol-related phenotypes
Aim 2: Advance our understanding of the longitudinal course of alcohol use and AUD, and its adverse outcomes
by studying genetic and environmental factors across the lifespan
Aim 3: Enhance understanding of brain functioning throughout the course of AUD and recovery, and
characterize alcohol related cognitive development and decline in the context of genetic and environmental
factors.
COGA's multi-pronged approach, long history of productive collaboration among the investigators and
commitment to data sharing, will allow us to propel the field of alcohol research towards actionable findings that
can be positioned to translate science to population health and clinical care. The gestalt that arises from the
integration across COGA's research modalities (genomics, brain function, lifespan) is only possible within a U10
mechanism that supports effective collaboration between researchers with diverse toolkits aimed at addressing
the serious public health challenge of AUD.

Public health relevance
Alcohol Use Disorders (AUD) are a major social and health problem, the prominence of which continues to grow in mid-life and later life. The Collaborative Study on the Genetics of Alcoholism (COGA) is a tightly integrated and interdisciplinary project, whose overarching goals are to understand the contributions and interactions of genetic, neurobiological, and socio-environmental factors on risk and resilience over the developmental course of AUD, including relapse and recovery. The three COGA projects (Genomics, Brain Function, Lifespan), supported by three cores (Administrative, Data Management and NIAAA/COGA Sharing Repository) aim to address the public health challenge of AUD by integrating findings across multiple domains of research. By crafting a more integrated view of the architecture of AUD, COGA is well poised to inform future efforts aimed at curbing the deleterious consequences of AUD on persons and the population.